Communicating Lung Dysfunction to the Brain in Alzheimer's Disease

Summary
An estimated 5 million individuals have Alzheimer’s disease (AD) in the US, which is expected to grow to 16
million by 2050. Identifying and mitigating relevant environmental risk factors is a current strategy to slow or
prevent AD progression. The growing appreciation of peripheral to brain immune cell communication during
disease progression suggests that chronic peripheral inflammatory disease may influence brain changes
during AD. Based upon the fact that asthma prevalence increases in the elderly, we will test the idea that a
lung-brain communication axis can potentiate AD by focusing mainly on asthma pathophysiology. Our
preliminary data using a mixed allergen-induced mouse model of asthma demonstrated a significant increase
in brain cytokines in female mice, validating possible crosstalk of inflammation between the lung and brain.
Moreover, examining a transgenic AppNL-G-F mouse model of AD, we observed basal lung dysfunction and
increased APP expression in the lung epithelium due to AD. More importantly, asthma induction in these mice
increased brain Aβ levels, supporting the notion that there is not only altered lung inflammation because of AD,
but additional lung inflammatory stress potentiates AD pathology in the brain. We will fully characterize the
temporal changes in AD-related lung dysfunction in Aim one and determine whether lung epithelial APP or Aβ
is responsible for the unique AD-associated lung dysfunction. In Aim two, we will use a genetic approach to
assess whether attenuating APP expression or Aβ production specifically in the lung is sufficient to attenuate
an asthma phenotype but also the ability of asthma to potentiate brain changes in AD mice. Finally, in Aim
three, we will determine whether pharmacologic inhibition of Aβ production in AD mice is sufficient to
ameliorate an asthma phenotype and exacerbation of AD. This study will define a novel aspect of AD that
involves lung dysfunction and a largely uncharacterized ability of asthma to communicate changes to the brain
to exacerbate AD. We will also illustrate a bi-directional lung-brain axis in asthma and AD in which either
condition can increase the risk or severity of the other. The outcomes of our work will provide a new
understanding of disease comorbidities that may be relevant to needs beyond AD. Finally, we will define a
novel approach to attenuate AD by targeting changes outside the brain.

Public health relevance
Narrative Alzheimer’s disease is a significant cause of death worldwide, with the number of cases expected to increase steadily over the next several decades. Although age is an obvious risk factor, there are likely environmental influences on disease progression. For example, although asthma has well-known effects on the respiratory system, it is clear that this lung disease can communicate to the brain. We demonstrate that asthma can increase brain inflammation in healthy mice and even worsens disease-related brain changes in a mouse model of Alzheimer’s disease. Based upon the fact that asthma is a common, chronic lung inflammatory disease often comorbid with Alzheimer’s disease, we hypothesize that uncontrolled asthma contributes to the progression of Alzheimer’s disease. Interventions targeting lung dysfunction due to asthma may have the added benefit of slowing the progression of Alzheimer’s disease.